Migraine, Depressive Symptoms, and Maternal Quality of Life in the Postpartum Period: The Role of Comorbidity, Disengagement, and Social and Economic Disadvantage

Migraine affects one in three women of childbearing age in the United States (U.S.). Women with migraine
have up to a five-fold increased risk for comorbid depression. The postpartum period is an especially
challenging time for women with migraine, as rapid hormonal shifts, fatigue, exhaustion, and increased
external stressors are known triggers for both migraine and postpartum depressive symptoms. If women’s
migraine self-management style (MSMS) primarily involves disengagement (i.e. social withdrawal, avoidance,
wishful thinking), the implications for developing depressive symptoms and synergistically worsening
symptoms across conditions may be more significant. These risks may be exponentially more harmful to
women who have lower levels of personal resources (PR) that have been shown to facilitate effective chronic
disease self-management in other non-migraine disease states, as they experience the greatest burden from
migraine and postpartum depressive symptoms. A syndemic is characterized by the (1) higher prevalence of
these co-occurring disorders, and (2) synergism that exists across symptoms and self-management strategies
of one condition (migraine) that facilitates developing a comorbid condition (depression) are influenced by (3)
social contextual factors (social and/or economic disadvantage in the face of postpartum demands). Despite
the high prevalence of these disorders individually, the increased risk for comorbid migraine-depressive
symptoms in the postpartum period, and the potential impact on women and their families, there is a paucity of
research in this area. The proposed study will use a syndemics framework to understand the relationships,
mechanisms, and interactions among migraine and depressive symptoms, disengagement, and level of PR
over the first 3 months postpartum. This will be accomplished by the following:
Aim 1: Examine the relationships among (a) migraine symptom severity, (b) depressive symptom
severity, (c) level of disengagement as a migraine self-management style, and (d) level of personal
resources, over time.
Aim 1a: Test the extent to which disengagement mediates the relationship between migraine
symptom severity and depressive symptom severity.
Aim 1b: Determine whether the level of personal resources moderates the extent to which
disengagement mediates the migraine-depressive symptom relationship.
Aim 2: Compare maternal quality of life among women who develop the syndemic factor (comorbid
migraine and moderate-to-severe postpartum depressive symptoms) and women who do not.
The applicant has outlined a comprehensive training plan to be completed under this award. Outcomes of the
study and training plan will provide the applicant with skills and data to pursue a career development award on
prevention-oriented interventions targeting syndemic conditions that may be useful in disrupting the
development of postpartum depressive symptomatology among women with migraine.

Public health relevance
One in three women of childbearing age has migraine, and postpartum depression is the most common complication of childbirth. This study will provide foundational evidence on how migraine and postpartum depressive symptoms are related, and whether level of personal resources that have been shown to facilitate effective chronic disease self-management in other non-migraine disease states, along with disengagement as a migraine self-management style, influence the development of postpartum depressive symptoms among women with migraine. Findings may contribute to improved interventions for women with migraine that delay or reduce depressive symptoms in the postpartum.